A Comparative Approach to Uncovering the Cellular and Circuit Basis of the Role of the Corticospinal Tract in Motor Skill

PROJECT SUMMARY
The goal of the proposed research is to discover how variation in the number of corticospinal neurons
(CSNs) causes variation in motor circuit function and dexterous behavior, thus linking cells, circuits,
and behavior in the same system. The evolution of advanced cognitive and motor function is associated with
cerebral cortex expansion, including expansion of CSN neuron number, and it has long been hypothesized that
the expansion of CSNs in primates underlies their exquisite hand dexterity, such as that required for tool use.
In support of this, lesioning studies have demonstrated a role for motor cortex, and CSNs in particular, in
dexterous behaviors. However, CSN number has not been causally linked to dexterity, nor do we understand
the basic principles of how expanding a cell population alters circuit activity and thus behavior. The
experiments proposed here will test the hypothesis that animals with more CSNs have greater
dexterity, thus synthesizing cellular, circuit-level, and behavioral discovery, thus achieving the Goal 7
of the BRAIN Initiative. Specifically, this research will compare subspecies of deer mice (Peromyscus
maniculatus) that evolved in different habitats and have innate differences in dexterity as well as a difference in
CSN number. First, it will use single-nucleus RNA-sequencing to characterize which population(s) of CSNs
differ in abundance between subspecies and to identify candidate developmental mechanisms underlying CSN
population expansion. (Aim 1). At the circuit level, this research will determine whether neural activity during a
dexterity task and neural architecture, as assessed with viral tracing, differs between subspecies (Aim 2).
Finally, in the candidate’s independent research program (R00 phase), she will use the tools and datasets
generated in Aims 1 and 2 to manipulate CSNs to establish causal links between CSN number, neural activity,
and dexterity (Aim 3). This project will take advantage of recent technological advances in high throughput
experiments (e.g., single nucleus sequencing) and neural manipulation (e.g., virally delivered gene editing) to
work in a non-traditional model system, affording the unique ability to capitalize on naturally evolved behavioral
differences to elucidate general principles of how cellular and neural variation mediate behavioral variation.
This research is part of a comprehensive training plan that combines training in comparative behavior,
developmental and systems neuroscience, and computational analysis of datasets in these areas, as well as
training in communication and mentoring. This plan will be mentored by Dr. Hopi Hoekstra at Harvard
University, an expert in deer mouse comparative behavior, and Dr. Adam Hantman at the University of North
Carolina Chapel Hill, an expert in the neuroscience of motor systems. Additional mentorship will come from an
Advisory Committee in single cell sequencing analysis, developmental neuroscience, and analysis of neural
recording data. Together, this opportunity will provide excellent training for an independent research career in a
unique, interdisciplinary niche at the interface of molecular neuroscience, behavior, and evolutionary biology.

Public health relevance
PROJECT NARRATIVE An evolutionary expansion of the cortex, in particular corticospinal neurons, has long been hypothesized to underlie the exceptional dexterity of primates, but it is unclear how this expansion affects neural circuits and whether there is a causal link between corticospinal neuron number and dexterous behavior. Deer mice (Peromyscus maniculatus) are a uniquely advantageous system in which to address this problem as an experimentally tractable system with innate natural variation in motor skill that correlates with variation in corticospinal neuron number. This proposal thus aims to use deer mice to test the hypothesis that the expansion of specific corticospinal neuron populations results in changes in neural activity and dexterous behavior, thus fulfilling the seventh goal of the BRAIN Initiative by integrating across levels of understanding to contextualize cell types in circuit function, and circuit function in behavioral output.